Novel Protein Phosphatases

DESCRIPTION (provided by applicant): Members of the protein tyrosine phosphatase (PTP) super family contain the highly conserved active site motif, Cys-x5-Arg (Cx5R), and are key mediators of a variety of cellular processes including growth, differentiation, motility, metabolism, and programmed cell death. This proposal focuses on the mitochondrial phosphatase, PTPMT1 (formerly PLIP), the first resident mitochondrial phosphatase to be identified and functionally linked to energy metabolism in the cell. PTPMT1 is a highly conserved phosphatase with over 60 orthologs throughout the Animalia, Plantae, Protista, and Eubacteria kingdoms. There is no precedent for PTPs in the mitochondrion, and no known mitochondrial signaling pathways involving reversible phosphorylation. We, therefore, performed several analyses of cells in which PTPMT1 had been ablated. A lipidomic analysis comparing the lipid profile of PTPMTI-ablated versus wild type cells pointed to phosphatidylglycerol phosphate (PGP) as the in vivo substrate for PTPMT1. PGP is an intermediate in cardiolipin biosynthesis, a key component of inner mitochondrial membranes. We propose to: 1) Synthesize PGP for in vitro analyses to demonstrate that PTPMT1 is a PGP phosphatase. We will also use this substrate with a variety of other phosphatases to determine if the ability to convert PGP to PG is an enzymatic activity unique to PTPMT1. Conversely, the ability of PTPMT1 to utilize other lipid phosphate substrates will also be assessed. 2) Address whether PGP phosphatase activity is conserved in selected orthologues. 3) Address the function of PTPMT1 in the inner mitochondrial membrane. We propose to quantitate the effects of PTPMT1 expression on rates of cardiolipin biosynthesis, as well as examine the mitochondrial morphology and bioenergetic status of PTPMT1 deficient cells. 4) Determine the structure of PTPMT1 itself and in combination with PGP. These experiments will allow a detailed understanding of how PTPMT1 exhibits such unusual phospholipid substrate specificity. Our results will shed light on the possible roles of PTPMT1 in various diseases where reduced cardiolipin has been reported, such as ischemia, heart failure and diabetes, and provide insight into novel points of therapeutic intervention for these diseases.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project is focused on the mitochondrial phosphatase, PTPMT1. We have proposed that its endogenous substrate is phosphatidylglycerol phosphate, an important intermediate in cardiolipin biosynthesis, a key component of mitochondrial membranes. Thus, PTPMT1 function is intimately linked to mitochondrial function, which plays a critical role in ageing and diseases such as diabetes. Project Narrative This project is focused on the mitochondrial phosphatase, PTPMT1. We have proposed that its endogenous substrate is phosphatidylglycerol phosphate, an important intermediate in cardiolipin biosynthesis, a key component of mitochondrial membranes. Thus, PTPMT1 function is intimately linked to mitochondrial function, which plays a critical role in ageing and diseases such as diabetes. __SpecificAimsTextDelimiter__ 2. Specific Aims This grant DK018849 is now in its 35th year. My other NIH grant is a MERIT award (DK018024), which focuses on the structure and function of the phosphoinositide phosphatases. This proposal focuses on the novel mitochondrial phosphatase, PTPMT1. This phosphatase is unusually highly conserved and has over 60 orthologs throughout the Animalia, Plantae, Protista, and Eubacteria kingdoms. Because of the superficial similarity to PTEN, we initially named the protein PTEN-Like Phosphatase (PLIP). Because the name PLIP was already in use, we renamed our phosphatase Mitochondrial Protein Phosphatase 1 (PTPMT1), since it was the first Cx5R phosphatase shown to have an exclusively mitochondrial localization. Specifically, PTPMT1 associates tightly to the mitochondrial inner membrane facing the matrix. Initially, PTPMT1 caught our attention because it was identified as an open reading frame (NCBI accession: XP-374879), encoding a phosphatase with a PTEN-like active site, CKAGRSR. The positions of the basic amino acids (bold) in the active site are thought to confer the ability to use phosphoinositides as substrates and indeed, our initial characterization of this PTP indicated that its preferred substrate was PI(5)P. In our efforts to characterize the cellular function of PTPMT1, we asked if knock-down of PTPMT1 using RNAi strategies would alter endogenous levels of PI(5)P. The knock-down of PTPMT1 had no effect on cellular levels of this phosphoinositide, suggesting that PI(5)P was not a physiologically important substrate. In order to study the function of PTPMT1 in a physiologically relevant context, we genetically engineered mice in which the PTPMT1 gene has been ablated through homologous recombination. MEFs were isolated from embryos with two conditional Ptpmt1 alleles (flox/flox). Recombination at the loxP sites and loss of PTPMT1 protein expression is achieved by infection with an adenovirus expressing Cre recombinase. We compared the lipid profiles obtained from Flox (control) MEFs to those obtained from KO MEFs and detected an increase in phosphatidylglycerol phosphate (PGP) levels paired with a decrease in phosphatidylglycerol (PG) levels. This suggests that PGP is the endogenous substrate for PTPMT1. The conversion of PGP to PG is central to the biosynthesis of cardiolipin. Therefore, our preliminary findings suggest that PTPMT1 plays a critical and unexpected role in cardiolipin synthesis, a phospholipid known to be important in mitochondrial function. In Specific aim 1, we propose to synthesize PGP for use in in vitro phosphatase assays. This PGP will be used for kinetic analyses of PTPMT1. We will also determine the substrate specificity of PTPMT1 and assess whether other PTPs can use PGP as a substrate. Specific aim 2 addresses whether PTPMT1 orthologues from the kingdoms noted above can utilize PGP as a substrate. We will express recombinant evolutionarily distinct putative PTPMT1 orthologues from Arabidopsis thaliana, Dictyostelium discoideum and Rhodopirellula baltica and compare their activities with that of PTPMT1 in our in vitro phosphatase assay. Specific aim 3 focuses on the function of PTPMT1 in mitochondria. First, we will correlate PTPMT1 expression with cardiolipin biosynthesis. Next, we will determine how the expression of PTPMT1 relates to mitochondrial morphology and membrane integrity. Finally, we will address how loss of PTPMT1 affects the bioenergetic status of mitochondria. Because of the unusual nature of its substrate, we propose to solve the crystal structure of PTPMT1 in Specific aim 4. We have collected data to 2 Å for the crystal structure of apo PTPMT1Δ31 and are well on our way to the solution of this structure. We also propose to solve the structure of PTPMT¿31 complexed with its substrate. Although this is an ambitious aim, we have previously been successful in obtaining the structure of a lipid phosphatase complexed with its substrate. The Specific Aims for this proposal are: 1. Characterize the enzymatic activity and substrate specificity of PTPMT1 2. Cross-species analysis and characterization of PTPMT1 orthologs 3. Characterize the functions of PTPMT1 in mitochondria 4. Determine the structure of PTPMT1 alone and complexed with PGP The successful completion of this grant will advance our understanding of the kinetic and biochemical properties of the mitochondrial lipid phosphatase, PTPMT1. It will also increase our understanding of mitochondrial bioenergetics and relate mitochondrial function to the biosynthesis of cardiolipin. Altered cardiolipin levels are tied to many human diseases including heart disease and diabetes, two of the most prevalent diseases plaguing mankind.